Evaluating Use and Expenditures on Low Quality Breast Cancer Care in the Medicare Program

Project Summary
The provision of low-value (quality) care, defined as services for which the potential for harm outweighs
the potential for benefit, is estimated to account for more than $300 billion in health care expenditures annually
and thus has critical consequences for patients and the overall health care system (Koziara 2020). Over the
past decade, initiatives such as the Choosing Wisely (CW) campaign and the Less is More series sponsored
by JAMA Internal Medicine have raised awareness of the magnitude of the problem. (Because most published
studies use the term “low-value” we adopt this terminology as equivalent to low-quality). Several studies
constructed indicators of low-value care from claims data; most measures were diagnostic test or imaging
procedures (Schwartz et al. 2014; Mafi et al. 2021; Segal et al. 2014; Colla et al. 2015). Research to date
shows that the CW campaign had little impact on reducing the use of low-value care. Early-stage breast cancer
(BC) is a highly prevalent condition for which several metrics of low-value care have been identified by
oncology and surgical specialty societies. Thus, efforts to reduce the use of these low-value services will likely
yield substantial cost savings. Private Medicare Advantage (MA) plans have a unique toolkit which can be
used to reduce the use of low-value care. For example, MA plans may require prior authorization for high-cost
procedures, provide incentives for beneficiaries to seek care from a network of “high value” providers and
employ financial incentives to influence physicians’ prescribing patterns. In contrast, fee-for-service or
“traditional” Medicare (TM) does not impose such constraints and restrictions on patients’ choice of providers
or procedures deemed to be of low-value. In addition, different types of MA plans (health maintenance
organizations (HMOs) and preferred provider organizations (PPOs)) face varying financial incentives that are
likely to influence efforts to reduce use of low-value care. Yet, most previous research either compares all MA
plans in aggregate to TM or focuses solely on MA-HMO plans. Comparisons of TM vs MA-PPO plans are
nonexistent. Our aims to examine early-stage BC (stages 0, I, IIA, IIB and IIIA) are:
Aim 1: To assess differences in receipt of low-value (quality) BC care for women newly diagnosed with
early-stage BC across TM and specific types of MA plans, including TM vs MA-HMO plans and TM vs MA-
PPO plans, after controlling for individuals’ self-selection into a TM, MA-HMO plan, or MA-PPO plan, patient
demographic and clinical characteristics and breast surgeon practice structure.
Aim 2: To evaluate incremental spending on low-value BC care among women age 70 and older with
early-stage BC enrolled in TM and comparable measures of spending (resource use) among similar women
enrolled in MA-HMO plans and MA-PPO plans, after controlling individuals’ self-selection into a TM, MA-HMO
plan, or MA-PPO plan, patient demographic and clinical characteristics and breast surgeon practice structure.

Public health relevance
Project Narrative The provision of low-value (quality) care, defined as services that provide little clinical benefit relative to their cost, has reached epidemic proportions in the US accounting for more than $300 billion in health care expenditures annually (Kozeara 2020). Private Medicare Advantage (MA) plans have unique toolkit which can be employed to curb the use the low-value care whereas such options are not available in traditional Medicare (TM). Our comparisons of MA-HMO vs TM and MA-PPO vs TM will provide new insights as to whether specific MA plans are effective in reducing the use of low-value care for early-stage breast cancer.